Sex-Dependent Regulation of Host Factors Influencing SARS-CoV-2 Infection and COVID-19 Disease

Project Summary
COVID-19, the disease caused by the SARS-CoV-2 virus, commonly presents as pneumonia, with those most
severely affected progressing to Acute Respiratory Distress Syndrome (ARDS). Notably, males seem to be at
significantly higher risk for severe or fatal outcomes from COVID-19, and male-specific skewing was also
observed with related coronaviruses SARS-CoV and MERS. The X chromosome is enriched for immunity-related
genes, and females (XX) mount stronger immune responses than do males (XY). X-chromosome Inactivation
(XCI) normalizes the gene dosage effect between the sexes and we have previously found that immune cells
have novel and dynamic XCI mechanisms that allow for gene-specific transcriptional activation from the inactive
X (Xi) in a cell-type specific manner. Notably, our preliminary data suggest the regulation of XCI in lung alveolar
type 2 (AT2) cells, the predominant target of SARS-CoV-2 in the lung and a cell type critically involved in lung
repair following viral injury, phenocopies that seen in immune cells. As such, we will test the novel hypothesis
that X-linked genes, including immune genes and ACE2, escape XCI in a lineage-specific fashion and contribute
to the relative resistance of females to COVID-19 (Aim 1). We will test the hypothesis that our novel humanized
ACE2 mice, which are susceptible to SARS-CoV-2 infection, will exhibit sex differences with resulting lung
pathologies in aged mice (Aim 2). Together, these studies will further our understanding of the mechanisms that
predispose males to COVID-19 disease and will reveal novel strategies to reduce disease severity.

Public health relevance
Project Narrative Men are at significantly higher risk for morbidity and mortality from COVID-19, and the SARS-CoV-2 receptor ACE2, required for viral entry, is localized to the X-chromosome. This collaborative study aims to determine whether epigenetic and/or hormonal factors might explain male susceptibility to severe COVID-19 in order to ultimately identify sex-specific strategies to prevent the more severe outcomes of COVID-19. We have generated a novel humanized ACE2 mouse model to facilitate COVID-19 disease modeling for future studies, and understanding the sex differences with SARS-CoV2 infection and COVID-19 pathologies.